Sympathetic Activation of Renal Dendritic Cells in Hypertension

Project Abstract
The goal of this proposed project titled “Sympathetic Activation of Renal Dendritic Cells during
Hypertension” is to investigate the role of renal dendritic cell (rDC) adrenergic receptor (AR) activation in
mediating cytokine-induced increases in sodium (Na) transporter activity and blood pressure (BP). Increased
sympathetic nervous system (SNS) activity is known to play a role in hypertension (HTN). Additionally, there is
an accepted role for inflammation in the pathogenesis of HTN. However, there is little data linking all these
physiological mechanisms in salt-sensitive HTN.
DCs cells secrete interleukin 6 (IL-6) producing a pro-inflammatory milieu. Our preliminary data show
that rDCs are necessary for salt-sensitive HTN (SS-HTN) and intra-renal IL-6 levels. Using RNAseq analysis of
whole kidney homogenates, we observed a change in the enrichment/Reactome pathway regulating AR
expression and signaling mechanisms. These changes were observed in mice lacking rDCs, suggesting a role
for AR in SS-HTN. Our robust in vivo data suggest that IL-6 infusion increases phosphorylated (pT53) NCC and
ENaC activity. We also show that IL-6, plus high salt (HS, 4%), increases BP after 3 days following an immediate
(day 1) reduction in urinary Na and total urinary volume. Together, these data strongly support a role for rDC-
mediating local IL-6 levels, IL-6 increasing Na transporter expression and/or activity as well as Na-dependent
BP. In this proposal, we hypothesize that SNS-mediated AR activation on rDCs increases intrarenal IL-6 levels,
activating distal tubular Na transporters and increasing blood pressure. We will investigate this using an
immortalized DC line (DC2.5), as well as freshly isolated rDCs. We will use radiotelemetry and mice lacking renal
DCs in a norepinephrine infusion model of HTN, as well as renal denervation during SS-HTN. These in vivo
studies will show dependence on rDCs for sympathetically-mediated HTN and renal innervation for renal IL-6.

Public health relevance
Project Narrative The central goal of this proposed work is to understand the integrated role of inflammation and the sympathetic nervous system in mediating increased sodium (Na) reabsorption during hypertension (HTN). Specifically, this work will explore adrenergic receptor activation on renal dendritic cells, and their contribution to cytokine- mediated increases in blood pressure. This study will allow new avenues for exploitation of possible therapeutic options. Reducing Na reabsorption will decrease blood pressure and end organ damage.